Family Therapy Training and Implementation Platform (FTTIP): An innovative web-based tool for long-term practice improvement

Project Abstract
Family Therapy Training and Implementation Platform (FTTIP) was developed to address
EBT training and implementation challenges. FTTIP uses adaptive training and
consultation processes that provide a dynamic and data-driven procedure in which a
competency is taught, measured, and the success or failure of the learning informs the
next step of training in real time. It provides interactive practice of skills in which the
trainee records interventions in response to simulation and receives personalized expert
feedback. The supplement project will have multiple components that augment the parent
study by collecting qualitative data that we can combine with the parent study’s
quantitative data to better understand the experiences of trainees and agency leaders
with the platform. Twenty trainees (randomly selected from the 75 CIFFTA parent study
trainees) and 16 agency leaders from the sample of the parent study will be included. The
proposed supplement aims to: 1) gather perceptions and experiences of the trainees
about the process of learning and practicing specific CIFFTA competencies from the
platform (time 1 interview) and later, about their unique experiences related to
implementation of the EBT, delivery of competencies learned, and the application of EBT
in a real-world context (time 2); and 2) gain a deeper understanding from leaders of their
experiences in facilitating EBTs at their agencies, the identification of barriers that can be
addressed by the organizational readiness work (time 1), and later regarding their
agencies experience with the platform, consultation process, perceived cost-benefit, and
agency readiness (at time 2). The proposed supplement also includes a comprehensive
career development and training plan during which the trainee gains experience in all the
issues relevant to planning, conducting, and reporting on randomized trials, state of the
art training and consultation processes, measuring family competencies, assessing, and
intervening in organizational readiness to implement EBTs, data analysis, dissemination,
and grant writing. Mentorship will include training in animation and simulation, quantitative
data analysis to assist in the analyses of data for the parent grant, and qualitative research
for the supplement study. Marketing and commercialization activities will include enrolling
in a marketing course and assisting the benefit cost analyses expert in the parent study.
Supplement study data will augment the parent study work in understanding the
leadership decision-making process regarding the selection of EBTs, and training and
implementation plans.

Public health relevance
Project Narrative The Family Therapy Training and Implementation Platform (FTTIP) was developed to better address EBT training and implementation challenges. The proposed supplement project uses qualitative research strategies to conduct in-depth examinations of individuals’ unique experiences with EBT’s, and of the barriers and facilitators experienced by both trainees and organizational leaders. The project also includes a comprehensive training and mentoring program that helps to diversify the pool of investigators that conduct small business research.